An Integrated In Vitro 3D Model of Human Bone Marrow and Peripheral Infection

PROJECT SUMMARY
The primary goal of the supplement to be carried out by Ms. Zarate-Sanchez is to design, build, and validate
an integrated “organ-on-a-chip” platform of human primary tumor and human bone marrow. This is important
because: 1) all tumors engage the immune system, and thus the bone marrow (primary source of immune
cells); and 2) a wide range of tumors co-opt the bone marrow to the advantage of the tumor during progression
and latency (e.g., breast cancer). The research milestones include: 1) demonstrate proficiency in all steps of
soft lithography, including CAD design, photolithography, and PDMS device construction; 2) demonstrate
proficiency in cell culture techniques; and loading and culture of in vitro bone marrow and cancer models in the
microfluidic device; 3) quantify number, phenotype, and location of the leukocytes within the microfluidic device
in response to a series of breast cancer cell lines; and 4) quantify number, phenotype, and location of a series
of breast cancer cells lines in the microfluidic device. In addition to the research milestones, the supplement
will seek to accomplish a series of milestones associated with her career development including: 1) completing
3 elective courses; 2) mentoring undergraduate researchers; 3) presenting her work at a national meeting; 4)
publishing her work in a peer-reviewed archived journal(s); and 5) submitting her own independent F31
application. Accomplishing these milestones will prepare Ms. Zarate-Sanchez for an independent and
impactful scientific career.

Public health relevance
PROJECT NARRATIVE The central objective of this supplement request is to support the salary, travel, and supplies associated with the doctoral studies of Ms. Evelyn Zarate-Sanchez.